Biomedical Research Experience for Veterinary Students

As determined by several studies there is a critical national need for veterinarians
in the biomedical research community. The long-term objective of this NRSA Short-Term
Institutional Research Training Grant, Biomedical Research Experience for Veterinary
Students (BREVS), continues to be the attraction of veterinarians to careers in
biomedical research. There are two aims, first is a short-term independent research
project in an environment of discovery provided by an active laboratory and mentor. The
program spans the natural life of a research project. It is designed to afford the student
the opportunity to help plan the studies to be conducted, conduct a literature review,
develop a research proposal, conduct the experiments, and present the data as it
evolves and when the project is completed. While these projects are designed to be
completed during the summer, local students have the opportunity to continue their work
during elective blocks during the second, third and fourth years of the veterinary
curriculum. Secondly, the program will provide students with significant, non-laboratory
research relevant experiences in the form of lectures, discussions, field trips, and team
building exercises. Topics for lectures and discussions will include experimental design
and data analysis, research communication, literature searching and evaluation, the use
of animals in research, ethics, animal welfare, and the responsible conduct of research.
Specific lectures by local experts on contemporary topics such as stem cell biology,
translational medicine, and training and career opportunities in biomedical research will
continue to be organized. Field trips will expose the scholars to the research
environments of a primate center, medical research institute, medical school campus,
and biomedical research companies in a technology center. Together these events will
begin to provide the scholars with an understanding the diversity and depth of research
opportunities available to them when they graduate. With the renewal or this grant, the
BREVS program will continue with 8 NIH scholars for 5 additional years of support. This
is consistent with our success, the increased interest in the program, and our continuing
efforts to attract additional students from other CVMs. The intent of the program is to
immerse the professional students as a group and individually into an exciting, science
based problem-solving environment which has at its center an identifiable research
project.

Public health relevance
Realizing a national need for veterinarians in the biomedical research community, this program immerses professional students as a group and individually into a research setting. Activities to educate students on the responsible conduct of research are combined with exploration of various research enterprises in order to attract veterinarians to careers in biomedical research. !